3D Shearwave Elasticity Biomarker Development for Neuromuscular Disease

Neuromuscular disorders, including Duchenne's Muscular Dystrophy and Pompe disease, are progressive and
often result in signiﬁcant disability and sometimes death. Encouragingly, novel enzyme replacement and ge-
netic therapies are becoming available, but they are associated with detrimental side effects and assessing their
efﬁcacy remains a challenge. Current methods used to assess muscle health are subjective, non-quantitative,
and focus on muscle quantity and strength; however, measuring muscle quantity can over-estimate the amount
of functional muscle, and muscle strength tests are affected by patient cooperation, pain, and co-morbidities.
There is an urgent and unmet clinical need for a low-cost, non-invasive biomarker to accurately assess
muscle health, monitor disease progression, and determine treatment response. Ultrasonic shear wave
elasticity (SWE) imaging methods estimate the biomechanical properties of soft tissues, and these methods
have demonstrated promise in the characterization of healthy and diseased muscle; however, commercially-
available SWE methods are limited to estimating material parameters from a 2D imaging plane, and measure-
ment variability and challenges with ﬁber alignment have limited clinical adoption. We have developed a 3D-
SWE imaging system and advanced reconstruction algorithms with which we have obtained preliminary
in vivo data that demonstrate, for the ﬁrst time, the complex 3D shearwave behaviors generated by SWE
excitations in vivo in skeletal muscles, and have observed signiﬁcant differences between patients with
myopathy that are consistent with clinical strength metrics. We have developed reconstruction algorithms
that leverage the 3D-nature of these data to estimate multiple independent material properties, including: the
longitudinal and transverse shear moduli, the shear anisotropy, the tensile anisotropy, and the viscosity along
and across the muscle ﬁbers. We hypothesize that the more complete material characterization afforded by
these measurements will provide improved biomarkers of muscle health. We now propose to optimize the se-
quencing and minimize the 3D data acquisition time; to automate and validate our parameter reconstruction al-
gorithms; and to quantify the parameter measurement accuracy and precision in calibrated elasticity phantoms.
Finally, we propose a pilot clinical study in which we will quantify and compare 3D-SWE muscle parameters
in vivo in patients with myopathy and muscular dystrophy and in healthy controls, evaluate the repeatability of
these measurements, and assess their correlation with clinical measures of muscle health. Successful com-
pletion of this project will provide non-invasive quantitative biomarkers of muscle health on a low-cost
portable platform, enabling frequent measurement and longitudinal monitoring of disease progression
and treatment response which will facilitate personalized and optimized neuromuscular disease man-
agement.

Public health relevance
Project Narrative We will develop a 3D ultrasonic shear wave elasticity imaging system and use it to non-invasively measure the mechanical properties of skeletal muscle and to determine their relationship to muscle health; this system will ultimately be used to assess muscular deﬁcits associated with neuromuscular diseases and to determine how well therapeutic treatments are working and when they should be modiﬁed, which will both improve treatment efﬁcacy and reduce the number of muscle biopsies performed in these patients.